Sensory-evoked adenosine release in cortical plasticity

Abstract
Neural circuits in sensory cortices are plastic, i.e., their properties change as new environmental information is
integrated based on its behavioral value. The capacity of acoustic stimuli alone to induce plasticity in the auditory
cortex (ACx) abruptly declines with age. In adults, ACx plasticity is induced during attentive wakefulness or by
pairing acoustic stimuli with the activation of neuromodulatory systems, such as the cholinergic nucleus basalis
or dopaminergic ventral tegmental area. It can also be induced in adults by passive exposure to acoustic stimuli
during experimental juvenile-like weakening of adenosine signaling in glutamatergic thalamocortical inputs to the
ACx. How the neuromodulatory systems interact with adenosine to refine cortical circuits is unclear. Recently,
we identified an event we have termed “sound-evoked adenosine release” (SEAR) in the ACx of awake adult
mice as a key gatekeeper for auditory cortical plasticity and improvement in auditory frequency-discrimination
acuity (perceptual plasticity). SEAR originates from the thalamocortical projections via ecto-5ʹ-nucleotidase
activity and becomes transiently reduced when acoustic stimuli are tightly paired with the activation of cholinergic
or dopaminergic circuits. These seconds-long low-adenosine conditions permit stimulus-specific associative
cortical and perceptual plasticities to occur. We, therefore, hypothesize that transient low-adenosine periods
triggered by activity in neuromodulatory circuits are prerequisites for sensory stimuli to produce behaviorally
significant cortical plasticity in adults. In this proposal, we aim to elucidate the developmental and spatiotemporal
characteristics of SEAR in the ACx by using fast-scanning cyclic voltammetry, which directly detects extracellular
adenosine with sub-second temporal resolution and 2-photon imaging of the ACx using the genetically encoded
fluorescent adenosine sensor GRABAdo. We also propose to test if the SEAR decrease driven by
neuromodulatory activity affects cortical plasticity of inhibitory neurons in the ACx. These experiments are
inspired by the notion that sensory and neuromodulatory conversion occurs at the level of the excitatory/inhibitory
balance, as the neuromodulators act through disinhibition of local inhibitory microcircuits to enhance the
excitability of the cortical excitatory neurons. Lastly, we propose to elucidate the mechanisms of SEAR decrease,
which depend on neuromodulatory activity. Specifically, we will determine whether equilibrative nucleoside
transporters in astroglia and thalamic adenosine production regulate the level of extracellular adenosine during
neuromodulatory activities. Together, these experiments will enable us to characterize in detail the mechanisms
of SEAR as a key gatekeeper of cortical and perceptual plasticities in adults.

Public health relevance
Relevance: Sensory cortices undergo substantial changes during learning of behaviorally important information. In this proposal, we will elucidate how sound-evoked adenosine release controls synaptic and cortical plasticities in the murine auditory cortex and affects perceptual performance.